TEMPORAL SUMMATION OF SECOND PAIN IN SLEEP DEPRIVATION AND FIBROMYALGIA

The purpose of this study is to obtain new information on fibromyalgia and to identify the role that sleep abnormalities play in this disorder.